Socio-Cultural Stress Profiles, Stress Responses, and Health in Mexican American Adolescents

This project is in response to PA-17-042 and examines the longitudinal influence of socio-cultural stressors, physiological and behavioral stress responses to these stressors, and health outcomes of adolescents in Mexican immigrant families. Recognizing the challenging social environments in which adolescents in Mexican immigrant families are embedded, this project creates socio-cultural stress profiles comprised of economic stress, discrimination and foreigner stress, and language brokering experiences (in which children translate between English and Spanish for their English-limited parents). Our ongoing research with adolescents in Mexican immigrant families has identified three socio-cultural stress profiles (moderate, protective, risk), three stable profiles over time (stable moderate, stable protective, stable risk), and two socio-cultural change profiles over time (improved, declined). The proposed project builds on a successful study of adolescents in Mexican immigrant families (PI: Kim, NSF, BCS-0956123 and BCS-651128; NIH, R03HD060045) to examine, prospectively, the influence of socio-cultural stress profiles in middle school alone, as well as continuity and change in socio-cultural stress profiles from middle school to high school, on adolescent health (Aim 1). Specifically, this grant will allow the research team to add measures of physiological health outcomes, namely inflammation (IL-6, C-reactive protein) and diabetes risk (hemoglobin A1c). We will also test a pathways model, to determine whether socio-cultural stress profiles are associated with adaptive or maladaptive physiological and behavioral stress responses that influence health (Aim 2). Further, we propose to test whether the associations from socio-cultural stress profiles to stress responses to health outcomes are exacerbated or mitigated through various moderators, including personal (resilience, parent support) and cultural (family obligation) resources, stress related to legal status, and language brokering places and content (Aim 3). Physiological stress response will be assessed via cortisol. Acute cortisol will be assessed by measuring reactivity and recovery to an adaptation of the Trier Social Stress Test, in which adolescents verbally translate a medical document for their parents. Day-to-day cortisol will also be measured. Substance use and sleep are self-reported daily, and motionlogger watches worn on the wrist provide an objective assessment of sleep. This study is very much in line with the 2016-2020 NIH strategic plan of studying normative populations to detect points for preventive interventions to reduce health disparities. It does so by studying socio-cultural stress profiles that include language brokering experiences, a common phenomenon in low-income Mexican immigrant families that has received little attention to date. We examine the complex conditions under which socio-cultural profiles can function as sources of both risk and protection for adolescents. This project has the potential to uncover processes and practices that can reduce persistent health disparities in Mexican immigrant families.

Public health relevance
PROJECT NARRATIVE The proposed study is relevant to public health because it focuses on the health outcomes of children of Mexican immigrants, a population with high rates of poverty, low levels of educational attainment, and a high risk for cardiovascular disease and diabetes. It also focuses on the developmental period of adolescence, a vulnerable phase of life characterized by social and physical changes, during which behaviors that are predictive of adult health first become established. The results of this project should inform researchers and interventionists about how to support adolescents in Mexican immigrant families, by identifying how a confluence of socio-cultural stressors may function as adaptive or maladaptive, to mitigate the most damaging effects and enhance the payoffs of growing up in a Mexican immigrant family.